Neural Substrates Controlling Metabolic and Reproductive State

PROJECT SUMMARY
The goal of this project is to find new neural substrates governing metabolic state in Drosophila melanogaster.
Success of organisms through evolutionary time depends upon their ability to optimize utilization of resources.
When environments become unfavorable, animals will preserve energy and attenuate reproduction. This strategy
requires perception and assessment of a complex environment, which is an ancient role of the nervous system.
Many metabolic disorders in humans, such as polycystic ovarian syndrome, remain incompletely understood,
but probing an underlying role for the nervous system remains a monumental challenge. Here, we propose to
exploit the genetic accessibility and cellular resolution experiments possible in the fly, Drosophila melanogaster,
to explore how the brain sets metabolic and reproductive state. Given the importance of environmental
adaptation, we expect the biological principles underlying these strategies to be highly conserved among motile
animals with nervous systems, including flies and humans. The Meiselman lab seeks to establish a network map
for the nervous system components that permit the fly brain to change metabolic state, thereby laying
groundwork for investigations in organisms with brains of higher complexity.
During my postdoc I showed that DN3 circadian neurons and expression of their operant neuropeptide,
Allatostatin-C (AstC), are temperature-sensitive and terminate cold-induced reproductive arrest when warm
temperatures return. In this proposal, we will find the minimal neural subset that depends on temperature
information from DN3s and adjusts reproductive output, then examine how their innate activity responds to
temperature change with calcium imaging (Aim 1.1). Next, we will determine if the minimal subset controlling
reproduction causes changes to rhythmicity, feeding, and metabolic rate (Aim 1.2). We will then investigate a
second subset of neurons that depress reproduction when activated, heart-innervating LkAC neurons. We will
assess their role in modulation of metabolism (Aim 2.1) and examine if their activity affects heartbeat (Aim 2.2).
Finally, we will find the molecular (Aim 3.1) and neural (Aim 3.2) substrates that attenuate reproduction in
response to noxious percepts (hunger, thirst, and high heat). In sum, this work will offer comprehensive insight
into how the nervous system integrates sensory information to control metabolic state and reproduction.
This project will present opportunities for diverse students at a minority-serving institution (UNLV) to
engage in research which utilizes cutting-edge techniques. My co-mentors Dr. Mariana Wolfner and Dr. Frank
van Breukelen, and collaborators Drs. Allen Gibbs and Nilay Yapici collectively have world-leading expertise in
fly genetics, metabolism, and neurobiology. Their support will allow me to foster a successful laboratory
environment wherein I can offer top notch mentorship to my students and reach my career goals. In addition to
critical technical skills, my mentors will offer me guidance that will allow me to establish a successful extramurally
funded research program, and to unveil new insights into the interface between brain and metabolic state.

Public health relevance
PROJECT NARRATIVE The goal of this project is to discover the neural substrates that link perception and assessment of environment to metabolic and reproductive output. I will leverage the accessibility of the nervous system in Drosophila melanogaster to isolate neurons and signaling molecules that control fly reproduction and metabolism, which may uncover new circuitry linking brain and metabolic state. This work offers the prospect of discovery of pathways which may underly idiopathic metabolic disorders in humans and offer broad biological insights into how animals coordinate metabolism with environment.